Core 3: Biostatistics, Data Management, and Bioinformatics

Project Summary
The major objective of the Biostatistics and Bioinformatics Core (Core 3) is to provide centralized biostatistics,
bioinformatics, and database support for all Projects and Cores. Core 3 will provide guidance in the design and
conduct of clinical trials and other experiments that arise from the ongoing research of the SPORE, facilitate
prospective collection, entry, quality control, and integration of data for the basic science, pre-clinical, and
clinical studies, and provide bioinformatics data analysis of high-throughput and high-dimensional genomics
data. We will provide innovative and tailored statistical modeling, simulation techniques, and data analyses for
the main projects, developmental research and career enhancement projects, and other cores to achieve their
specific aims. We will conduct data analyses and prepare statistical reports for all experiments within all
projects, ensure that the results of all projects are appropriately interpreted, and assist all project investigators
in the publication of scientific results. Core 3 will also be a resource for intra- and inter-SPORE collaborations,
including study design and developing databases for multi-center clinical trials.

Public health relevance
Project Narrative The Biostatistics and Bioinformatics Core provides consultation and collaboration in the design, conduct, analysis, and interpretation of research studies in this SPORE, helps them achieve their objectives and ensures scientifically valid conclusions will be drawn. Effective formulation and application of efficacy, futility and safety monitoring rules for clinical trials will offer protection to patients.